SPLENIC EMBOLIZATION--HYPERSPLENISM AND PORTAL HYPERTENSION

Splenic artery embolization an therapy for children with either critical hypersplenism or with esophageal variceal hemorrhage secondary to portal vein thrombosis; evaluation of residual splenic function following embolization of the organ.